Utah Rapid Response Team Level 2 Maintenance

URRT- Project Summary- 2023-RFA-FD-23-019- Development and Maintenance of Human and
Animal Food Rapid Response Teams (U2F)
Project Summary
This is a three-year capacity building project. The Utah Rapid Response Team (URRT) has
been separated from the Utah Manufactured Food Regulatory Program (UMFRP) and continues
to build the capacity of the URRT. The URRT has outlined several important goals for the next
three years, key among them are: increase outreach and education, coordination of outbreak
response in human and animal food, maintain a readiness status for emergency response, and
continuation of long term sustainability through the Utah Rapid Response Steering Committee.
We continue to work with local, state, federal, and tribal partnerships to maintain and improve
food safety culture throughout the state of Utah.

Public health relevance
URRT- Project Narrative- 2023-RFA-FD-23-019- Development and Maintenance of Human and Animal Food Rapid Response Teams (U2F) Project Narrative The overarching goals of the Utah Rapid Response Team for this three-year project are to: Goal 1- Increase outreach,education, and training a. Objective 1.1- participate in conference presentations b. Objective 1.2- provide training opportunities c. Objective 1.3- remain active through committee participation Goal 2- Coordinate outbreak response in human and animal food a. Objective 1.1- maintain relationships with subject matter experts b. Objective 1.2- refine and use the URRT activation criteria c. Objective 1.3- continue to update the emergency response list Goal 3- Maintain a readiness status for emergency response a. Objective 1.1- ensure all equipment is up to date and in good working order, including supplies to run an Incident Command Post as needed b. Objective 1.2- maintain proper equipment logs c. Objective 1.3- open lines of communication with partners Goal 4- Continue long term sustainability through the Utah Rapid Response Steering Committee a. Objective 1.1- continue monthly meetings b. Objective 1.2- maintain steering committee members including epidemiology, environmental health, laboratory, feed, local, state, federal, and tribal food safety experts c. Objective 1.3- track in kind contributions to show the depth of membership involvement Goal 5- Continue to work with local, state, federal, and tribal partnerships to maintain and improve food safety culture throughout the state of Utah a. Objective 1.1- continue to sponsor an annual food safety conference b. Objective 1.2- continue to be actively engaged with our state Emergency Operations Center c. Objective 1.3- continue to support national RRT committees to improve food safety practices Goal 6- Keep our standards current and support the Manufacture Food Program, Produce, Local Health Departments, Animal Feed, and others a. Objective 1.1- maintain Standard 3- Inspection Program (Recalls) b. Objective 1.2- maintain Standard 5- Food-related Illness, Outbreaks and Emergency Response c. Objective 1.3- maintain Standard 7- Industry and Community Relations